TOLRESTAT FOR NEPHROPATHY PREVENTION IN MICROALBUMINURIC TYPE 1 DIABETES

Type I diabetics with microalbuminuria are destined for progressing renal disease. Tolrestat, a new type of aldose reductase inhibitor, may block the glucose to polyol pathway and prevent disorderd phosphoinositide metabolism, which may prevent diabetic renal disease.